Delaware INBRE

Project Summary – Overall
The overall mission of the Delaware INBRE (DE-INBRE) program is to further grow a collaborative, multidisciplinary
biomedical research network in Delaware that creates and supports sustainable collaborative research programs
that address strategic health issues for the State, embraces diversity, and produces a positive impact on Delaware’s
workforce and economy.
The DE-INBRE network consists of six Partner Institutions: the lead institution, University of Delaware; three minority-
serving primarily undergraduate institutions (PUIs), Delaware State University, Delaware Technical Community
College, and Wesley College; and two medical institutions, Christiana Care Health System and Nemours/Alfred I.
duPont Hospital for Children. Three Affiliated Institutions joined the network in 2017, including the Wilmington Veterans
Affairs Medical Center, Wilmington University, and Delaware BioScience Association.
The DE-INBRE’s five administrative and scientific cores provide research support and capacity building. The
Administrative and Evaluation Core manages network activities with a rigorous evaluation program. A Centralized
Shared Resources Core provides state-of-the-art research instrumentation and scientific expertise via a network of
core facilities. A broadly engaged Bioinformatics Core supports inter-institutional research initiatives and training needs.
The Education and Professional Development Core engages Delaware’s faculty, clinicians, and a diverse population
of students with exceptional mentors. Finally, the Developmental Research Project Program supports Pilot Project
investigators in cancer, cardiovascular, and neuroscience thematic areas.
Specific Aims
1. Grow a strong and sustainable biomedical research capability in Delaware.
2. Enhance the capacity of Delaware’s biomedical research network.
3. Embrace diversity across Delaware’s biomedical research, industrial, and patient care networks.
4. Enhance the biomedical science and technology knowledge of Delaware’s workforce.

Public health relevance
Project Narrative The Delaware INBRE program focuses on addressing the region's greatest risks to health through research. Basic and translational research in cancer, heart disease and brain function is supported, and researchers, clinicians and students are trained within a well-integrated network of academic and clinical institutions across the state. The goal is to further strengthen Delaware's health research efforts, create health-related jobs and improve the lives of Delawareans.